Study Pro-Oncogenic Role of BCL6 in CLL Tumorigenesis

PROJECT SUMMARY
Chronic lymphocytic leukemia (CLL) is an adult B-cell malignancy accounting for about a third of leukemia
diagnoses in the US. While B-cell receptor (BCR)-signal-inhibitors are changing the management of CLL, these
are not curative and resistance can develop; often leading to more aggressive disease. Given this, understanding
the molecular events driving CLL oncogenesis and therapeutic resistance warrants in-depth investigation.
CLL shows remarkable clinical heterogeneity, with some patients pursuing an indolent course, while others
progress rapidly and require early treatment. Extensive heterogeneity exists also at the genetic, epigenetic, and
transcriptional level. In addition to constitutively active BCR signal, we previously reported the existence of a
highly active receptor tyrosine kinase (RTK) AXL in CLL cells regulating multiple signal mediators including LYN,
PI3K/AKT and PLCγ2 thus, potentiating CLL cell survival signals.
B-cell lymphoma 6 (BCL6) is a transcriptional repressor and proto-oncogene that plays a crucial role in the innate
and adaptive immune system and lymphoid neoplasms, regulating numerous genes involved in DNA damage
and cell proliferation. Most recently, we have detected expression of BCL6 in CLL cells from previously untreated
CLL patients both at mRNA and protein levels. Our preliminary findings indicate that HSP90 overexpression may
regulate BCL6 protein levels in CLL cells. Importantly, our initial data also suggest that aberrant expression of
BCL6 may regulate the highly active AXL survival signal in CLL cells. However, the mechanism of aberrant
upregulation of BCL6 in CLL cells, and its precise functional contributions to CLL biology and disease
pathogenesis are poorly understood. It is also not clear if the target transcriptional landscape of aberrantly
expressed BCL6 in CLL cells is different than that is detected in normal germinal center B-cells. Therefore, the
central hypothesis of this application is that overexpression of BCL6 in CLL cells represents highly aggressive
disease with shorter time to therapy. We also postulate that BCL6 upregulation potentiates CLL cell survival
signals and resistance to BCR-targeted agents. We propose – Aim 1: Evaluate if BCL6 upregulation in CLL cells
drives disease progression; Aim 2: Define the mechanism of BCL6 upregulation and its role in CLL cell biology
and signaling.
The proposed in-depth studies will assess if “high BCL6” level in CLL cells serves as a risk factor for CLL
progression, time to therapy and treatment outcome; define the impact of BCL6 aberrant expression on CLL cell
survival and resistance to current BCR-targeted therapies. Thus, the proposed studies have great potential to
establish a new prognostic parameter and therapeutic avenue via targeting BCL6 in CLL cells in combination
with the current BCR-targeted therapy, ibrutinib.

Public health relevance
PROJECT NARRATIVE Relevance to Public Health This grant proposal will develop a robust and comprehensive analysis of the expression status of a previously undefined proto-oncogene, BCL6 in chronic lymphocytic leukemia (CLL) which we have detected recently in CLL cells however; functional implication of this aberrantly expressed transcriptional repressor in CLL tumorigenesis remains largely unknown. The proposed studies are dedicated in novel and important directions: 1) to establish if aberrant expression of BCL6 in CLL cells represents high-risk CLL patients' cohort for aggressive disease and/or predicts time to therapy; 2) delineate the mechanism of BCL6 upregulation in CLL cells; 3) define the function of BCL6 in CLL cell survival and therapeutic outcome of the patients and finally, 4) assess the feasibility of targeting aberrantly expressed BCL6 alone or in combination with B-cell receptor-targeted agents (e.g., ibrutinib) to induce apoptosis in leukemic B-cells both in vitro and in vivo in a CLL-specific established mouse model. In total, the information gained on the aberrantly upregulated BCL6 in CLL cells in relation to disease progression and our goal on developing increasing rationale for the use of BCL6-inhibitor alone or in combination with the current targeted therapies for CLL has great potential to impact and improve public health.